Administrative Core

The purpose of this Core is to provide a central location for administrative and fiscal support for all projects. Specifically this Core will offer the following services: 1. Coordinate all internal and external meetings related to the program project 2. Provide fiscal management support including budgeting, purchasing, and account managements 3. Assist in personnel matters, including hiring, payroll, and travel 4. Ensure adherence to regulatory guidelines for animal care, chemical hygiene, radioactivity, biosafety, and use of human subjects 5. Facilitate the submission of progress reports in timely manner 6. Provide server and web site management 7. Provide support for statistical analyses Centralization of these functions will permit an efficient use of resources for the Program and ensure that all administrative needs are performed in a manner that adheres to regulatory guidelines.